Investigating the Role of MYC in Meibomian Gland Oncogenesis

PROJECT SUMMARY/ABSTRACT
Sebaceous carcinomas (SebCA) of the ocular adnexa (OA) most frequently arise from the specialized
sebaceous glands of the eyelid (Meibomian glands, MGs), and commonly exhibit local invasiveness with
intraepithelial spread into the conjunctiva. These aggressive features complicate complete surgical excision and
increase the risk for distant metastasis, resulting in a mortality rate of up to 40% of affected patients. While
alterations in TP53 and/or RB1 and syndromic loss-of-function mutations in mismatch repair genes have been
associated with OA SebCA, the genomic landscape of this tumor remains largely unresolved. I recently
demonstrated MYC overexpression in a subset of OA SebCA, both with and without amplification at the MYC
locus, and many of the high-MYC tumors also harbored mutations and copy number alterations in components
of the insulin/insulin-like growth factor signaling (IIS) pathway. The effects of dysregulated IIS on MYC
expression and malignant transformation of the MG remain unresolved, and MYC overexpression as driver of
OA SebCA has not been previously evaluated. The hypothesis underlying this proposal is that MYC
overexpression in meibocytes is initiated through dysregulated IIS, resulting in enhanced proliferative potential
and cell survival in addition to local immunosuppression. I further predict that MYC overexpression, alone, is
insufficient for malignant transformation of meibocytes, requiring the acquisition of tumor suppressor mutation.
As such, the objectives of this proposal are to determine the role of IIS on MYC expression in meibocytes,
characterize the molecular and transcriptomic changes associated with IIS modulation in meibocytes,
understand the impact of both on cells in the local microenvironment, and define the temporal relationship
between MYC overexpression and TP53 loss-of-function with respect to malignant transformation of the MG in
vivo. To accomplish this, Aim 1 will assess the impact of pharmacologically and genetically modulated IIS on
cell behavior, transcriptional landscape, and MYC expression in normal and neoplastic meibocytes in vitro, while
Aim 2 will define the effects of modulated MYC expression on phenotypic features and the transcriptional
landscape of normal and neoplastic meibocytes in vitro. Additionally, the consequences of MYC overexpression,
in the presence or absence of Trp53 inactivation, on the MG and local microenvironment will be determined
using genetically engineered mouse models. The rich research environment afforded by Tufts University, the
Tufts Clinical Translational Science Institute, and associated partners ensures access to resources and expertise
necessary for completion of the proposed work. My training in veterinary pathology, vision science, and
molecular biology, along with guidance from my mentoring team with expertise in comparative immuno-oncology,
pathology, IIS, and MYC biology, will facilitate successful completion of milestones outlined in this application
and the transition to an independent clinician scientist in the field of comparative ocular pathology and oncology.

Public health relevance
PROJECT NARRATIVE Carcinomas arising from Meibomian glands, the specialized sebaceous glands of the eyelid, exhibit aggressive phenotypes, resulting in worrisome rates of local recurrence and metastasis, which are often refractory to treat- ment, despite sight-threatening surgical resection. The genomic determinants driving these features of malig- nancy in ocular adnexal sebaceous carcinomas remain poorly resolved. Interrogating the upstream regulation and downstream consequences of MYC expression in the initiation and progression of these tumors will provide new information that may facilitate the development of precision therapies for affected patients world-wide.